Systems Biology of Lipid Metabolism

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Systems Biology of Lipid Metabolism, organized by Matej Oreai, Antonio J. Vidal-Puig and Ana Maria Cuervo. The meeting will be held in Breckenridge, Colorado from February 9-13, 2015. Lipid homeostasis is fundamental to the maintenance of good health. Due to the enormous functional and structural diversity of lipids as well as because of their complex regulation at multiple spatial and temporal scales, lipids need to be studied not only at the level of biological pathways but also at the level of the biophysical systems they are part of including cellular membranes or lipoprotein particles. From the perspective of systems biology, this adds an additional but necessary layer of complexity to the studies of lipids. This Keystone Symposia meeting will cover recent progress and perspectives in the studies of lipids as related to: 1) Cellular as well as systemic lipid metabolism; 2) Computational modeling of lipids; and 3) The role of lipids in the pathogenesis of several complex diseases including metabolic, immune and central nervous system disorders as well as cancer. Specifically, experts in this area will address whether alterations in lipid biology may be an important underlying pathogenic link among these disorders, which could explain the well documented metabolic co-morbidities such as between obesity and several other complex diseases. The meeting will bring together a highly interdisciplinary outstanding group of scientists including biochemists, molecular and cellular biologists, clinical researchers and computational biologists. Such a diverse setting will facilitate the cross-disciplinary interactions needed to address current key questions in lipid biology in the context of translational medicine as well as move the field of lipids forward by consolidating the use of systems biology approaches to study their involvement in the pathogenesis of common diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lipids are a diverse group of metabolites that have many key biological functions, acting as structural components of cell membranes, energy storage sources and intermediates in signaling pathways. Altered lipid metabolism plays important roles in the pathogenesis of most of the common diseases. The Keystone Symposia meeting on Systems Biology of Lipid Metabolism will examine the roles of lipids in different diseases, as well as address the hypothesis that the alterations in lipid biology may be an important underlying pathogenic link among some of these disorders, which could explain the well documented co-morbidities related to obesity.